Stakeholder Perspectives on Family Caregiver Involvement in Oncology Clinical Trial Decision-Making

Project Summary/Abstract
Current informed consent practices for oncology clinical trials focus on individual autonomy and fail to account
for the complex obligations and relationships that influence decision-making. Family caregivers are influential
in medical decision-making for cancer patients, yet little is known regarding how they are included in clinical
trial discussions and what is important to them when considering participation. Clinical trial staff are primarily
responsible for informed consent in oncology trials and maintain ongoing contact with patients and caregivers,
yet they are also overlooked in clinical trial decision-making research. This study aims to fill this knowledge gap
using qualitative methodology to elicit perspectives from family caregivers and clinical trial staff, key
stakeholders in oncology clinical trial decision-making. The specific aims are: (1) to understand how family
caregivers of patients with cancer conceptualize their role in clinical trial decision making, (2) to determine
factors influential to family caregivers of patients with cancer during the clinical trial decision-making process,
and (3) to identify attitudes, beliefs, and approaches used by clinical trial staff to navigate family caregiver
involvement in the informed consent process for clinical trials. Two focus groups will be conducted, one with
oncology clinical trial staff and one with family caregivers of patients with cancer. Thematic analysis of focus
group data will refine interview guides for subsequent semi-structured interviews with family caregivers.
Results will inform future bioethics research, policies, and practice regarding inclusion of family caregivers in
clinical trial informed consent processes.

Public health relevance
Project Narrative Focus groups with family caregivers and oncology clinical trial staff will be conducted to understand how family caregivers navigate oncology clinical trial decision-making and current practices regarding their inclusion in informed consent. Subsequent in-depth interviews with family caregivers will provide further detail about how they conceptualize their role in decision-making and what factors motivate them to support or discourage participation in clinical trials. Results will contribute to building an evidence base for informed consent processes in oncology clinical trials and will inform future bioethics research.